Synthesis of Carbohydrate-Phthalocyanine Conjugates for Biomedical Applications

PROJECT SUMMARY
Phthalocyanines are macrocycles that meet all the criteria for an effective photosensitizer including absorption
in the near infrared region between 700-1100nm for deep tissue penetration, and high singlet oxygen generation
for maximum cell killing. However, the same properties that make phthalocyanines ideal photosensitizers from
a photophysical perspective limit their therapeutic applications in biological systems. Phthalocyanines are known
to exhibit limited solubility in water, tend to aggregate in biological fluids, and exhibit limited selectivity toward
the targeted tissues. Several general approaches have been used to improve the pharmacological profile of
phthalocyanines, including functionalization of the isoindole (outer) rings with sulfates or other water-soluble
moieties such as quaternary amines. While these approaches have shown some success, their preparation still
suffers from inefficient chemistries at key synthetic steps leading to low yielding reaction mixtures that can be
difficult to separate and evaluate for pharmacological activity. In addition, the current methods for preparing these
phthalocyanines are not readily amenable to tuning (e.g., to create libraries to study their applications in biological
systems). Their challenging synthesis has also limited the installation of groups that might be used to enhance
the overall selectivity of these compounds. This proposal addresses these issues through the modular synthesis
of glycoconjugated phthalocyanines (GPc’s). In addition to providing enhanced solubility, carbohydrates with
targeting ability (e.g., through the direct binding of lectins that are overexpressed on cell surface, or through the
engagement of carbohydrate binding enzymes that play key roles in metabolic processes) can be used to
enhance selectivity. Our innovative methodology, which will allow us to prepare libraries of GPc’s, relies on the
synthesis of readily accessible phthalocyanine-based bromosynthons which can be selectively substituted with
linkers bearing functional handles for glycoconjugation. In this way, both the linker and carbohydrate can be
exchanged to tune the system for a desired biological application. In this proposal we also explore the ability of
the GPc’s we synthesize to address two global public health issues in line with NIH initiatives: hepatocellular
carcinoma and tuberculosis. Given our experience, long-standing successful collaboration, and combined
expertise and resources, we, as multiple PIs from Davidson College and USC-Upstate, are uniquely qualified to
co-lead this effort, which will be our second R15 initiative together. This R15 AREA proposal will support an
exceptional research experience for multiple undergraduates at each institution and foster the training of the next
generation of synthetic chemists.

Public health relevance
PROJECT NARRATIVE Phthalocyanines have emerged as promising next generation photosensitizers for a wide range of biological applications. The deeper tissue penetration of light absorbed by phthalocyanine-based photosensitizers and their effectiveness at generating reactive oxygen species when activated provides a highly desirable clinical profile. However, their hydrophobicity and limited selectivity have limited their use in clinical settings. With support from the NIH, Dr. Snyder, Dr. Ruppel, and their undergraduate research fellows propose to prepare and evaluate a series of glycosylated phthalocyanines (GPc’s) with the potential address solubility and selectivity issues. Their work is proposed in the context of two major public health challenges: hepatocellular carcinoma and tuberculosis.